Defining the role of G3BP1 in vascular development

PROJECT SUMMARY/ABSTRACT
Proper blood vessel formation is essential for delivering blood to organs and tissues, crucial for their
development and function. However, aberrant blood vessel formation is associated with diverse pathologies
including tumor development and fibrotic scarring. Therefore, it is critical to understand the gene regulatory
networks underlying blood vessel formation so that these networks can be effectively manipulated during
pathological processes as a therapeutic approach. While great strides have been made in recent years to
uncover key mechanisms of transcriptional regulation in blood vessel development, relatively little is known
regarding post-transcriptional mechanisms that operate during this process. Post-transcriptional regulation
serves as the ultimate gatekeeper of protein output within a cell and thus is essential for cellular function during
tissue formation. RNA binding proteins (RBPs) bind directly to mRNA to control their stability, decay, and
translation into protein, and many RBPs have been correlated with highly angiogenic tumors. Yet, while RBPs
represent promising therapeutic targets, virtually nothing is known regarding roles for RBPs in the formation of
blood vessels. Evidently, investigating how RBPs regulate blood vessel formation through post-transcriptional
regulation will enhance our understanding of the gene regulatory networks underlying blood vessel formation in
health and disease. The overall objective of this study is to define the role of the RBP G3BP1 in blood vessel
formation. G3BP1 interacts with various components of translational machinery, influencing protein synthesis
dynamics in cells. Dysregulation of G3BP1-mediated translation has been implicated in various diseases,
including cancer and neurodegenerative disorders, but its role in regulating blood vessel formation remains
unknown.
I developed a novel g3bp1 loss-of-function mutant zebrafish that exhibit aberrant blood vessel formation. This
sets the foundation to tackle the following key questions: (1) what is the role of G3BP1 in blood vessel
formation? (2) is G3BP1 regulating blood vessel formation via interactions with translational machinery? To
answer these questions, we will utilize high resolution live imaging of developing blood vessels in zebrafish
embryos, tissue-specific protein degradation technology in vivo, 2D and 3D primary human cell culture assays,
and omics approaches to measure mRNA translation and the G3BP1 protein interactome.
This project will reveal G3BP1's role as anew regulator of blood vessel formationand will thus inform how its
function contributes to aberrant blood vessel formation in disease contexts, which may ultimately be
manipulated for therapeutic gain.

Public health relevance
PROJECT NARRATIVE Proper blood vessel formation in embryos is crucial for lifelong cardiovascular health. Understanding the molecular mechanisms behind this process, including the role of RNA binding protein G3BP1, is vital. G3BP1's regulation of blood vessel formation offers potential therapeutic targets for correcting issues in cardiovascular disease and cancer.